Assessing the mechanisms underlying female sex-predominance in Long COVID

PROJECT SUMMARY
Long COVID, or post-acute sequelae of COVID-19 (PASC), is estimated to occur after ~10% of COVID-19 cases
and affects tens of millions of people worldwide. The mechanisms underlying Long COVID remain poorly
understood, which hinders the ability to establish effective evidence-based treatments for the condition. One of
the most striking observations in the epidemiology of Long COVID is its female sex predominance: women,
particularly pre-menopausal women, are much more likely than men to have the condition. In this proposal, we
leverage the Long-term Impact of Infection with Novel Coronavirus (LIINC) cohort (NCT04362150) – which since
April 2020 has recruited >1,000 participants with and without Long COVID – to interrogate the mechanistic basis
underlying the increased prevalence of Long COVID in women. Our central hypothesis is that in women with
Long COVID, there is an elevated and sustained immune type I IFN (T1IFN) response to SARS-CoV-2 (SCV2)
gene products, which in turn diminishes the quality of adaptive immune responses against chronic herpesviruses
(EBV, CMV) and SCV2 itself, increases the risk of pathogenic autoantibody responses, and results in overall
systemic inflammation and immune dysregulation that is characteristic of Long COVID. We further postulate that
both incomplete X chromosome inactivation and sex hormones drive the elevated T1IFN responses in women
with Long COVID. In Aim 1, we will subject banked longitudinal blood specimens from women and men from
LIINC (including both those with and without Long COVID) to assays that will measure the extent of persistent
SCV2, T1IFN responses, the features of adaptive immune responses to persistent viruses associated with Long
COVID (SCV2, EBV, CMV), autoantibody responses, and the overall state of inflammation. In Aim 2, we will
leverage the LIINC Tissue Biopsy program to obtain paired endometrial and gut biopsies from women with Long
COVID, to test the hypothesis that the endometrium is a key site of SCV2 persistence and immune dysregulation
during Long COVID. This analysis will be compared to a parallel set of studies using gut specimens from matched
men with Long COVID. Finally, Aim 3 will analyze specimens from two clinical trials designed to eliminate SCV2
gene products as treatment for Long COVID. The first of these, performed by Resolve Therapeutics, found that
administration of RSLV-132, a catalytically active RNase1 intended to degrade SCV2 RNA, improved Long
COVID symptoms in women but not men (NCT04944121). The second, occurring within LIINC, is ongoing
(enrollment is complete) and testing the effects of AER002, a monoclonal antibody that directly targets and clears
SCV2 protein (NCT05877508). Using specimens from both trials, we will test the notion that SCV2 gene products
drive sustained T1IFN responses in women that contribute to Long COVID symptoms. Collectively, our aims will
improve our understanding of the mechanisms underlying the female-predominance of Long COVID and improve
our overall understanding of the disease. This will be a key step in the identification of evidence-based treatments
for both women and men who continue to develop and live with this disabling condition.

Public health relevance
PROJECT NARRATIVE Long COVID, a multi-organ disease that affects tens of millions of people worldwide, is significantly more prevalent in women than men due to poorly understood mechanisms. Here, using longitudinal blood and tissue specimens from women and men with and without the condition, we will test the hypothesis that sustained type I IFN responses to SARS-CoV-2 underlie the female predominance of Long COVID. These studies will be supplemented by analysis of specimens from interventional Long COVID clinical trials – including one that preferentially showed a beneficial outcome for women – designed to eliminate persistent SARS-CoV-2 gene products.